In situ forming implant drug delivery for non-addictive post-operative analgesia

PROJECT SUMMARY
The opioid crisis in the United States resulted in over 100,000 overdose deaths in 2022. Reducing opioid
prescriptions, particularly for acute pain, is crucial for minimizing substance use disorders. However, current
alternatives for pain management are insufficient, leaving opioids as the predominant treatment strategy.
Currently, the longest-acting analgesia available lasts only 72 hours; however, patients may experience pain for
up to 168 hours following oral facial surgery. Therefore, extending analgesia beyond 72 hours is critical for
effective postoperative pain relief. The proposed in-situ forming implant (ISFI) offers the potential for local
anesthetic release, regional nerve blocks, and acute and chronic pain treatment. We will use a poly(beta-amino
ester) (PBAE) microparticle derived from poly(ethylene glycol) diacrylate (PEGDA) and hyaluronate acrylate
(HA), incorporated into a poly(lactic-co-glycolic acid) (PLGA) system. This ISFI design will be gel-like prior to
complexation, and upon injection into an aqueous solution will form a solid. The PEGDA-HA microparticle will
be loaded with bupivacaine, ensuring all of the drug is in the inner layer of the polymer matrix, which is
hypothesized to reduce and potentially eliminate burst release, and rather yield a monophasic zero-order release
profile to ensure consistent drug release in the therapeutic window. Clinical oversight on this project is provided
by Dr. Gupta and materials design is provided by Dr. Givens and Dr. Hilt, who each have expertise in polymeric
drug delivery. The team has a history of successful collaboration and mentoring, ensuring effective research
execution. The research focuses on materials synthesis, characterization, and evaluation of bupivacaine release
profiles at different pH levels. Preliminary data indicate the feasibility of generating crosslinked acrylate systems
and ISFIs from these systems. The research objectives in this proposal are to achieve high bupivacaine loading
to minimize polymer volumes per injection and sustained release over a 168-hour therapeutic window. We will
also develop a biomimetic model to evaluate ISFI formation, degradation, and drug release in the orofacial
region. The successful completion of this project will provide novel information on PEGDA-HA systems for drug
delivery and the potential for ISFIs as long-term analgesic delivery for post-operative pain management.

Public health relevance
PROJECT NARRATIVE Acute pain relief may be treated through several analgesic strategies, including opioids; unfortunately, opioid addictions often lead to drug overdose and death and therefore present a significant health problem in the United States. The objective of this research project is to address acute pain relief with an in-situ forming implant (ISFI) loaded with bupivacaine hydrochloride for analgesia. Achieving this design will move us one step closer to reducing the burden of opioid prescriptions, addictions, and mortality without sacrificing patient comfort.